NEAR-UV LIGHT AND RETINAL DEGENERATION AND AGING

There is increasing concern that exposure to ultraviolet light, found in solar radiation, may be involved in the etiology of ocular disorders such as age-related macular degeneration. There is, however, an incomplete understanding of the mechanisms by which light stress leads to retinal pathology. The proposed research will investigate the role of near- ultraviolet light in causing retinal degeneration and aging. Recent findings in our laboratory have established pigmented rats as a suitable experimental animal for studying near-ultraviolet light toxicity of the retina. Using primarily the rat model and in some cases rabbits, experiments are specifically designed to 2) characterize near-ultraviolet light retinal damage in sub-primate mammals and distinguish it from the well-known form of retinal damage in these species that is caused by green light (i.e. rhodopsin-mediated damage); 2) evaluate the role of various endogenous chromophores in mediating or influencing near-ultraviolet retinal damage; 3) examine the possible involvement of lipid peroxidation in the biochemical etiology of near-UV retinal toxicity; 4) examine the influence of near-ultraviolet light stress on retinal aging; and 5) evaluate the relative contribution of different visible wavelength bands in causing retinal lesions produced by operating microscope light. A quantitative, multidisciplinary approach will be applied to these studies using electroretinographic, morphometric and various biochemical techniques. The intention of the proposed studies is to provide an in-depth analysis of the mechanisms by which near-ultraviolet light leads to retinal pathology. The information obtained from these studies could help to predict the conditions predisposing the retinal to near-ultraviolet damage and to devise strategies for preventing and managing photically-induced retinal disease.